Identifying Electrophysiological Targets for Transcranial Magnetic Stimulation in Cocaine Use Disorder

PROJECT SUMMARY
There is an urgent need to identify novel treatment targets for cocaine use disorder (CUD), as pharmacological
treatments have largely failed. The goal of this award is to evaluate the effects of transcranial magnetic
stimulation (TMS) on electroencephalogram (EEG) markers of reward functioning in adults with CUD. This goal
will be met by the research strategy and a rigorous training plan for Dr. Webber, who is uniquely positioned to
utilize electroencephalogram to assess TMS effects on the brain in CUD. Building on Dr. Webber's expertise in
cognitive neuroscience, electrophysiology, and addiction, the current career development plan will provide
training in: 1) transcranial magnetic stimulation research and clinical application, 2) advanced time-frequency-
based approach to electroencephalogram analysis, and 3) running an independent clinical trial. This training
will put Dr. Webber at the forefront of TMS development and mechanism identification for substance use
disorders and will position Dr. Webber as an independent investigator in addiction neuroscience. While TMS
has shown early success for treating CUD, there are important, yet addressable issues for optimizing TMS
treatment. First, the majority of studies have stimulated dorsolateral prefrontal cortex, yet many areas of the
prefrontal cortex are hypoactive in chronic cocaine use. Second, it is vital to identify reliable biomarkers to
identify targets for treatment and alternative end points in clinical trials. Electrophysiological markers (Reward
Positivity and Late Positive Potential) of reward sensitivity and motivated attention toward drug cues, two
factors that hinder treatment success and increase risk for relapse, hold promise for TMS manipulation. Third,
heterogeneity in TMS effects still need to be explained, which can lead to the improvement of individualized
treatment. The current study will compare a novel site, dorsomedial prefrontal cortex, to both sham and
traditional dorsolateral prefrontal cortex in a 3-arm, within-subjects, cross-over design to assess the acute
effects of TMS administration on the Reward Positivity and Late Positive Potential. This proof-of-concept study
will provide critical information on whether TMS administration has the potential to manipulate important reward
functioning deficits observed in CUD. This will be accomplished by: 1) Assessing the effects of TMS to the
dorsomedial prefrontal cortex and left dorsolateral prefrontal cortex compared to sham on the time-frequency
aspects of the Reward Positivity, 2) Assessing the effects of TMS to the dorsomedial prefrontal cortex and left
dorsolateral prefrontal cortex compared to sham on the Late Positive Potential, and 3) Identifying individual
differences in TMS effects with baseline characteristics (CUD severity, impulsivity, and craving). This work will
contribute to increasing knowledge of TMS in CUD and provide a strong foundation for the design and
submission of an R01 application in Year 5 of the K01 training, thereby launching Dr. Webber's progression
toward an independent research career. Ultimately, this work will lead to the development of optimal brain
stimulation procedures to treat CUD and other substance use disorders.

Public health relevance
PROJECT NARRATIVE Cocaine use disorder is a chronic, relapsing condition with severe public health impacts and limited effective treatment options. The current proposal aims to assess the acute effects of transcranial magnetic stimulation on electroencephalogram markers that contribute to poor treatment outcomes and has the potential to advance NIDA's objective of developing novel treatments that specifically target underlying neurobiological mechanisms of cocaine use disorder. This study can potentially improve transcranial magnetic stimulation treatment and ultimately lower the health burden of cocaine use disorder on the individual and society.